Transcriptional control of pituitary gonadotropin genes

DESCRIPTION (provided by applicant): Project Summary/Abstract Fertility depends on proper neuroendocrine regulation of the hypothalamic-pituitary-gonadal axis. Metabolic disorders, including obesity, are often characterized by hyperinsulinemia and associated with reduced fertility in women. Production of gonadotropin hormones critical for steroidogenesis, gametogenesis and ovulation is also disturbed in these disorders. The overall goal of this application is to determine whether gonadotropin gene expression is regulated by forkhead transcription factors in pituitary gonadotrope cells. FoxO proteins are regulated by insulin signaling and thus, may be an important regulatory link between metabolic status and fertility. FoxOs regulate diverse cellular functions, such as apoptosis, stress resistance and metabolism, but their role in the neuroendocrine regulation of reproduction has not been extensively explored. Our preliminary results indicate that FoxO1 is expressed in pituitary gonadotrope cells and that FoxO1 phosphorylation and cellular localization is regulated by insulin in these cells. Our preliminary studies also show that FoxO1 suppresses basal and GnRH induction of luteinizing hormone and follicle-stimulating hormone. Our hypothesis is that the FoxO1 transcription factor suppresses gonadotropin synthesis in pituitary gonadotrope cells and that insulin signaling relieves this suppression by rendering FoxO1 transcriptionally inactive. In this proposal, we will utilize novel approaches to study mechanisms of FoxO1 transcriptional regulation of gonadotropin synthesis in vitro and in vivo. In Specific Aim 1, a pituitary-specific knockout mouse model will be used to determine whether FoxO1 expression in the gonadotrope is necessary for fertility and whether FoxO1 plays a role in obesity-related infertility. In Specific Aim 2, biochemical and tissue cell culture models will be used to characterize mechanisms of FoxO1 regulation of gonadotropin production. Specific Aim 3 will address mechanisms of insulin signal transduction via FoxO1 in gonadotrope cells and determine if disruption of insulin regulation of FoxO1 impacts fertility using a conditionally active FoxO1 transgenic mouse model. Results from this proposal have the potential to answer fundamental questions regarding the role of FoxO1 in gonadotropin production and provide insight into broad mechanisms of hormonal control of fertility. Understanding these mechanisms may be relevant for the development of novel contraceptive methods or infertility treatments. Potential applications could also lead to new directions in treating a range of disorders that can result from malfunction in gonadotropin production, such as amenorrhea, precocious puberty, ideopathic hypogonadism, and polycystic ovarian syndrome. Funding of this proposal will also allow the PI, as an Early-Stage Investigator, to establish a fully-independent research program in the field of reproductive endocrinology.